Mechanism of Wnt5a signaling in skeletal development and diseases

The skeletal system provides crucial structural and functional support to the body. The long-term objective of
this project is to uncover the pathogenesis of congenital skeletal disorders and develop strategies for skeletal
regeneration by elucidating the key signaling mechanisms governing skeletal development. Early mouse
genetic studies have uncovered a critical role of Wnt5a in limb skeletal development. Human mutations in
WNT5A have also been implicated in Autosomal Dominant Robinow syndrome (ADRS), a disorder that
manifests dwarfism and widespread skeletal dysplasia. Studies over the past 20 years have revealed that
Wnt5a is a non-canonical Wnt ligand that signals through receptor Frizzled (Fz) and co-receptors Ror1/2 to
activate the planar cell polarity (PCP) pathway for limb morphogenesis during skeletal formation. The objective
of the current proposal is to characterize several fundamental properties of Wnt5a as a potent morphogen,
such as its signaling potency and range, the structural foundation that governs these properties, and how
human ADRS mutations alter its structure to modify WNT5A signaling. The objective will be achieved by
specifically testing 1) how two Wnt5a isoforms that differ by 18aa residues at the N-terminus may function
differently in PCP signaling to impact limb development; 2) how the Wnt5a isoforms and ADRS mutations may
alter the mode through which Wnt5a clusters together Fz and Ror to trigger PCP signaling; and 3) how the
ADRS mutations alter Wnt5a’s signaling potency and range during early limb development and endochondral
bone formation. Building on our preliminary studies that mouse transgenes encoding different Wnt5a isoforms
display remarkably different functional range in the limb, and that the two isoforms display different potency in
activating PCP in the Xenopus model, we will first determine whether their function range is solely determined
by the activity level difference, or additional factors such as dispersal ability during limb development.
Secondly, we will use a set of biochemical and biophysical assays to test a structural biology based model, in
which different N-terminal residues in Wnt5a isoforms and ADRS variants may alter the mode through which
Wnt5a brings together Fz and Ror to form distinct type of ligand/receptor complexes with different activity
levels. Thirdly, we will use a set of quantitative functional and molecular readout to determine how the ADRS
variants may cause elevated PCP signaling activity in Xenopus, and how these variants impact Wnt5a-
mediated skeletal development and endochondral bone formation in the mouse. These studies will elucidate
mechanistically how the N-terminal region may regulate Wnt5a’s signaling activity in PCP, and how alterations
in the N-terminus leads to skeletal defects in ADRS in humans.

Public health relevance
Wnts are a large family of signaling molecules with potent and widespread biological effects in the skeleton as well as development in general, stem cell maintenance, tissue homeostasis and cancer. This project will not only unravel how the structure of Wnt5a protein impacts signaling at the molecular and genetic levels, it will also shed light on the actions of other Wnt family members in diverse biological and disease processes. The fundamental knowledge gained from this project will help to elucidate pathogenic mechanisms in ADRS and provide crucial insight into the design of therapeutic interventions to treat skeletal disorders related to perturbation of Wnt/PCP signaling and be used to harness the power of Wnts for regenerative medicine.